Amplification of satiation signaling by melanocortin-4 receptors in the nucleus tractus solitarius

Project Summary The astounding prevalence of obesity presents major public health and economic consequences. The development of more effective therapeutics for weight loss is paramount and requires basic science research to characterize the neural control of feeding behavior. Melanocortin signaling, through melanocortin 4 receptors (MC4Rs) in the nucleus tractus solitarius (NTS) contributes to energy balance control by reducing food intake and increasing energy expenditure via amplification of within-meal gastrointestinally (GI)-derived satiation signals. However, the mechanism of MC4R signaling within the NTS is not clear and the translational significance of the interaction between NTS melanocortin signaling and other hormonal systems at the level of the NTS has not been adequately explored. The proposed research aims to test the hypothesis that endogenous pre- and postsynaptic NTS MC4R activity amplifies NTS neural signaling, food intake and body weight suppression and energy expenditure increases evoked by the GI-derived satiation signals cholecystokinin (CCK) and glucagon-like peptide-1 (GLP-1). Specific Aim I will use in vivo fiber photometry to examine bidirectional modulation of CCK- and GLP-1-evoked NTS neural activity by hindbrain delivery of the MC4R agonist MTII or antagonist Shu9119. We hypothesize that neural activity evoked by either of these satiation signals will be amplified by exogenous MTII and attenuated by Shu9119. As we hypothesize that potentiation of NTS neural activity will result in amplified satiation signaling and energy expenditure, we expect NTS delivered MTII to also enhance energy expenditure as well as the food intake and body weight suppressive effects of peripherally administered CCK or GLP-1. Specific Aim II will utilize an adeno-associated virus (AAV)- encoding cre-recombinase delivered to either the nodose ganglion of the vagus nerve or to the NTS of MC4Rlox/lox mice to selectively knockdown MC4Rs expressed on vagal presynaptic afferents or postsynaptic NTS neurons, respectively. We will analyze feeding behavior and energy expenditure in each of these groups of mice to dissociate the endogenous contribution of pre- and postsynaptic NTS MC4Rs to food intake, energy expenditure and body weight control. We will go on to use this strategy to examine the role of pre- and postsynaptic MC4Rs in mediating the intake-suppressive and energy expenditure-enhancing effects of exogenous NTS MTII delivery and in potentiating the anorectic actions of CCK and GLP-1. Finally, we will begin to characterize the phenotype of MTII-activated neurons within the NTS. By determining the functional relevance and mechanism of MC4R signaling within the NTS, these studies will contribute to identification of a novel NTS MC4R-activated circuit that may be manipulated through pharmacological approaches to reduce food intake and body weight.

Public health relevance
Project Narrative The prevalence of obesity in the United States is a devastating public health issue. Understanding the neural control of feeding behavior is necessary for the development of novel obesity treatments. The proposed work will determine the contribution of hindbrain pre- and postsynaptic melanocortin 4 receptors to the regulation of food intake, energy expenditure and body weight via the modulation of gastrointestinal (GI)-derived satiation signals.